Correlating Genomic AMD Risk Variants with Lipid Composition and Phagocytic Function of Patient-Derived Induced Pluripotent Stem Cell (iPSC)-derived Retinal Pigment Epithelium (RPE)

Supplementary Funding Request for U01 EY034594-01: "Correlating Genomic AMD Risk Variants with
Lipid Composition and Phagocytic Function of Patient-Derived Induced Pluripotent Stem Cell (iPSC)-
derived Retinal Pigment Epithelium (RPE)"
The supplement instructions for PA-20-272 states the following: “At a minimum, the Research Strategy section
should be completed and must include a summary or abstract of the funded parent award or project. Other sections
should also be included if they are being changed by the proposed supplement activities.”
The original Project Summary / Abstract document has not changed as a result of the proposed supplement
activities.

Public health relevance
Supplementary Funding Request for U01 EY034594-01: "Correlating Genomic AMD Risk Variants with Lipid Composition and Phagocytic Function of Patient-Derived Induced Pluripotent Stem Cell (iPSC)- derived Retinal Pigment Epithelium (RPE)" The supplement instructions for PA-20-272 states the following: “At a minimum, the Research Strategy section should be completed and must include a summary or abstract of the funded parent award or project. Other sections should also be included if they are being changed by the proposed supplement activities.” The original Narrative document has not changed as a result of the proposed supplement activities.